IARC Monographs on the Identification of Carcinogenic Hazards to Humans

Since 1971, the IARC Monographs on the Identification of Carcinogenic Hazards to Humans has provided an evidence-based approach to identifying the preventable causes of human cancer. Organizations worldwide rely on the IARC Monographs as a trustworthy source of carcinogenicity evaluations in their efforts to control cancer. Agents evaluated by the Monographs encompass chemicals, physical and biological agents, complex mixtures, occupational exposure circumstances, and other exposures of everyday life. To date, 1021 agents have been evaluated, with 121 classified as “carcinogenic”, 89 as “probably carcinogenic”, and 315 as “possibly carcinogenic” to humans. Agents are selected for evaluation based on evidence of human exposure and of carcinogenicity, and public health importance. Monographs are developed by independent global experts without conflicts of interest. Each Monograph includes systematic reviews of the pertinent scientific literature covering three unique streams of evidence (cancer in humans, cancer in experimental animals, and mechanistic evidence). The overall evaluations indicate the strength of the evidence that an agent or exposure may be carcinogenic to humans. These evidence evaluations are guided by a recently modernized Preamble, which emphasizes scientific rigor and transparency of the systematic review, updates the supporting methods, increases emphasis on mechanistic evidence, and advances an innovative method for integrating the three streams of evidence to produce robust overall classifications. The specific aims of this project are to: organize at least 10 Monographs meetings to evaluate candidate carcinogenic agents of high

Public health relevance
The Programme of IARC Monographs on the Identification of Carcinogenic Hazards to Humans identifies the preventable causes of cancer by convening expert working groups to conduct authoritative, internationally respected evaluations of suspected carcinogens, encompassing chemicals, physical and biological agents, complex mixtures, environmental and occupational exposures, and other exposures of everyday life. The resulting IARC Monographs are made freely available online to the public, and results are also disseminated through the scientific literature and other media. The IARC Monographs provide governments and health agencies in the United States and elsewhere with timely, trustworthy, authoritative scientific information to support actions to prevent cancer through control of exposure to known, probable, and possible human carcinogens.